Salmonella derived nanoparticles for cancer immunotherapy

Project Summary/Abstract
The overwhelming public health burden of HPV-associated head and neck cancer (HNC) has created
great demand for novel, broadly effective therapies with reduced treatment morbidity and improved long-
term survival. The generation of tumor-specific CD8+ T cell immunity requires potent antigen cross-presentation
by dendritic cells (DCs) since tumor cells do not efficiently present relevant CD8+ T cell epitopes. Because of
this, innovative strategies to enhance cDC1s could robustly induce HPV-specific immunity and have great
therapeutic potential in the treatment of HPV-associated HNC. FMS-like tyrosine kinase 3 ligand (Flt3L) is a
cytokine that expands and differentiates DC precursors to murine cDC1s. Furthermore, IFNβ is a type I
interferons, a major class of immune cytokines, that can act directly on CD8+ T cells to increase cytotoxicity and
survival by increasing the expression of cytotoxic T cell markers. However, therapeutic potential of Flt3L and
IFNβ is limited because of their short half-life and global distribution in vivo. We have overcome the described
issues by generating a genetic fusion of Albumin (Alb) to Flt3L, named Albumin-Flt3L (Alb-Flt3L), and the genetic
fusion of Alb to IFNβ, named Albumin- IFNβ (Alb- IFNβ). Alb has a long half-life due to FcRn mediated transcytolic
recycling. Once cDC1s expand, they require a strong, tissue localized source of inflammation for activation, or
they will present T cell epitopes without adequate costimulation, causing suppression. Enteric bacteria such as
Salmonella serve as an ideal agent for tumor specific cDC1 activation as they can provide numerous pathogen-
associated molecular patterns for cDC1 activation, and have been described to colonize the tumor efficiently
likely due to hypoxia. However, the use of heat-inactivated Salmonella results in weak immunogenicity and
potency. Therefore, something that is more potent and can penetrate tissue without the safety concerns of using
live bacteria is needed. We overcame this issue through the usage of Salmonella derived outer membrane
vesicles, which is considered safer and can effectively stimulate the immune system by presenting key
immunogens from their parent bacteria while also showing promise as a drug delivery agent. By coating SOMV
with 9RE7 peptide, we produced a novel approach of SOMV-9RE7 that serves as a safer and more effective
drug delivery agent. The combination of Alb-IFNβ, Alb-Flt3L, and SOMV-9RE7 capitalizes on the strengths
of these approaches, offering a synergistic strategy and valuable preclinical data for cancer treatment
by targeting multiple mechanisms and addressing cancer resistance in HPV-associated head and neck
cancers. Specifically, we will: Aim 1: Evaluate and compare the ability of Sal-9RE7 and SOMV-9RE7 to mediate
tumor control and induce HPV E7-specific T cell immunity. Aim 2: Evaluate the potency of the combination
treatment of Alb-Flt3L + Alb-IFNβ + SOMV-9RE7 to mediate tumor control and induce HPV E7-specific T cell
response. Aim 3: Characterize the mechanism of Alb-Flt3L + Alb-IFNβ + SOMV-9RE7 combination in mediating
antitumor immunity.

Public health relevance
PROJECT NARRATIVE In the current proposal, utility of our novel Salmonella derived outer membrane vesicles (SOMV- 9RE7) bacteria therapy + immunotherapeutic fusion protein of Albumin and FMS-like tyrosine kinase 3 ligand named Albumin-Flt3L (Alb-Flt3L) + immunotherapeutic fusion protein of Albumin and interferon-beta (Alb-IFNβ) in mediating tumor control through the expansion and activation of cross-presenting DCs and subsequent generation of HPV-specific antitumor cytotoxic CD8+ T cells will be investigated in spontaneous TC-1 HPV-associated head and neck cancer model. We will study how expansion and activation of cross-presenting DCs and CD8+ T cells by Alb-Flt3L + Alb- IFNβ + SOMV-9RE7 induce HPV E7-specific T cell responses and characterize the mechanisms in mediating antitumor immunity. The successful completion of this project will provide valuable preclinical and mechanistic data for future studies while delineating the therapeutic potential of enhancing HPV E7-specific antitumor immunity using Alb-Flt3L + Alb-IFNβ + SOMV-9RE7 for the treatment of HPV-associated head and neck cancer.